Comprehensive Augmented Reality Testing (CART) Platform for Parkinson’s disease

PROJECT SUMMARY/ABSTRACT
Parkinson’s disease (PD) is the fastest growing neurological disease, outpacing even Alzheimer’s. A gap in the
effective treatment of PD is the reliance on capacity-based clinical assessments, such as the MDS-UPDRS III,
to guide clinical decision-making. Clinical ratings, while simple to administer, provide a poor estimation of PD
performance of instrumental activities of daily living (IADLs). Declines in IADL performance are of particular
importance, as recent population-based cohort studies indicate that IADL decline pre-dates clinical diagnosis of
PD by 5-7 years and predict the transition from independence to dependent care settings. In order to advance
PD treatment and discovery, objective measures of disease symptoms during the performance of ‘real-world’
IADL scenarios must be created. Augmented reality technology, in which computer-generated images are
superimposed in the user’s real-world view, enable the presentation of digital scenarios to replicate IADLs and
objectively quantify user’s performance via integrated IMUs and depth camera. The primary aim of this project
is to develop an accurate, valid, and reliable augmented reality assessment platform for the quantification of
motor and non-motor performance of PD under clinical and IADL augmented reality environments. The
proposed Comprehensive Augmented Reality Test (CART) platform for PD will objectively quantify the cardinal
motor signs of PD, as well as IADL performance, to facilitate comprehensive treatment of symptoms and
precise tracking of disease progression that can eventually be used to optimize medication and deep brain
stimulation programming. A multi-disciplinary team of experts in the areas of software and biomedical
engineering, neurology, neurosurgery, neuropsychology, physical therapy and statistics will collaborate to
develop the CART platform and determine its accuracy, validity and reliability. Particular attention will be spent
on quantifying the interplay between motor and cognitive tasks, as dual-tasks performance is linked to gait
dysfunction and falls and historically has been overlooked in clinical assessments. Following the development
stage, a series of psychometric studies and analyses will be conducted to determine the accuracy, validity and
reliability of the CART platform in a cohort of 140 individuals with PD (n=35 in each Hoehn and Yahr Stage I-
IV) and 35 age-matched controls. The CART PD platform has the potential to transform the treatment of PD
globally by creating an equal emphasis on clinical symptoms and IADL performance through the use of an
affordable consumer-available electronic device that is suitable for the integration into treatment delivery
systems.

Public health relevance
PROJECT NARRATIVE The aim of this project is to bring together engineers and a group of multi-disciplinary clinicians to develop the Comprehensive Augmented Reality Testing (CART) platform to enhance the understanding and treatment of Parkinson’s disease (PD). The CART platform will utilize augmented reality technology to systematically evaluate motor and cognitive function and the performance of instrumental activities of daily living on a single technology platform. Following completion of software development, a series of validation and reliability experiments will be competed in 140 individuals with PD, evenly dispersed among Hoehn & Yahr stages, and 35 age-matched controls to ensure the CART platform provides accurate and actionable information about PD symptoms to ultimately advance PD treatment strategies and discovery.